A novel system for tracking arousal-related dynamics in freely moving animals

Abstract
High-speed, high-fidelity physiological readouts are critical to neuroscientists who aim to link these responses to
behavioral or neuronal activity. Despite the importance of these measurements, the current “gold-standard”
biometric monitoring technology in animal models greatly restricts the scope of experimental implementation. At
present, simultaneous tracking of these physiological measurements requires multiple bulky devices that must
be attached to the animal and synchronized with neural activity, inducing stress and limiting naturalistic animal
behavior. Carolina Instruments’ lightweight, freely moving Biometric Ocular Photometry (BOP) system
has the potential to address these challenges by simultaneously measuring multiple biometric readouts
in real time with minimal impediment to the animal. Our BOP technology leverages photoplethysmography
(PPG) techniques for the simultaneous measurement of pupil size, heart rate, and respiratory rate in mice.
Infrared (IR) light emitted from an LED positioned on the head passes through the brain and exits via the pupil,
where it is captured by a small sensor placed in front of the eye. IR light signal fluctuations are modulated by
pupil size, absorption due to blood oxygenation, and brain movement linked to respiratory activity. The compact
and lightweight nature of the LED and sensor enables this noninvasive approach to seamlessly integrate into
both head fixed and freely moving mouse experiments. Furthermore, the simultaneous real-time measurement
of each signal eliminates the need for complex and error-prone post-processing to synchronize the various
signals. The goals of this project are to make improvements to the hardware and data processing to prepare for
clinical translation.
Aim 1: Optimize the BOP system to maximize testing durability and minimize animal stress. Devices with
inadequate form factors can stress animals and limit the duration of experiments. We will address these
limitations with hardware adjustments to optimize device size and durability, making the technology suitable for
prolonged experiments in freely-moving mice. We will then validate the functionality of the freely-moving device
by collecting simultaneous pupil size, heart rate, and respiratory rate measurements, and comparing the results
to those from state-of-the-art biometric monitoring tools.
Aim 2: Improve the reproducibility of data collection and reporting. In its current state, our technology
requires an experienced user to perform surgery and to operate the device. We will implement hardware and
software modifications to ensure that surgical device placement and data collection become robust, repeatable,
and accessible to new users. A surgical placement tool will facilitate the repeatable placement of our baseplate
across animals, and a turn key self-calibration step will ensure that the device is properly operational before
starting experiments. Additionally, a signal processing algorithm will provide real-time assessments of data
reliability along with all reported data.
The completion of this project will lay the foundation for future work refining the device to prepare for large-scale
manufacturing, finalizing software infrastructure, and expanding to additional animal models.

Public health relevance
Narrative Mouse studies frequently employ biometric monitoring techniques to measure behavioral and neurological responses, a process which requires multiple bulky and/or complex instruments, impacting mouse behavior and limiting experimental capacity. Carolina Instruments is leveraging advanced optical techniques to simplify this process and collect multiple simultaneous biometric measurements in one small, lightweight device. This has the potential not only to increase the accuracy and scope of neurological mouse studies, but also to inform the design of human-interfacing devices for improved studies of mental health and neurological diseases.